Hypoxia-inducible factor(HIF)-driven modulation of alveolar regeneration

PROJECT SUMMARY
The current paradigm of Idiopathic pulmonary fibrosis (IPF) pathogenesis implicates recurrent injury and
dysfunctional repair of the alveolar epithelium which results in fibrotic lung remodeling and loss of functional
blood-gas exchange units. Current IPF treatments modestly slow disease progression by attenuating collagen
production by fibroblasts, but no available therapies stabilize disease nor facilitate functional lung repair. Our
overarching hypothesis is that therapies modulating upstream disease mechanisms to promote functional
alveolar repair could be transformative disease-modifying treatments for patients with IPF and other chronic
lung diseases. The loss of normal alveolar blood-gas barrier forming Alveolar Type 1 (AT1) and surfactant-
producing Alveolar Type 2 (AT2) cells has long been recognized in IPF and supported the concept that
dysfunction of epithelial progenitor cells is a key aspect of disease pathogenesis. Several disease-emergent
cell types identified in IPF (including KRT5-/KRT17+ aberrant basaloid cells) are abundant in areas of metaplastic
epithelial remodeling and active fibrosis, but their role in IPF pathogenesis remains uncertain. Interrogating our
single cell transcriptomic data, we identified significant enrichment of gene expression programs regulated by
the hypoxia-inducible factor (HIF) family of transcription factors in KRT5-/KRT17+ aberrant basaloid cells. Our
preliminary data using genetic and small-molecule based HIF2-targeting suggest that HIF2 inhibition
specifically can attenuate experimental lung fibrosis and enhance alveolar repair and regeneration in recurrent
injury. Additional studies using mouse and human derived alveolar organoid models demonstrate that HIF2-
inhibition enhanced AT2 differentiation and suppressed the emergence of aberrant intermediates similar to
disease-emergent cell states identified from IPF patients. Further, HIF2-biased activation in primary human
organoids suppressed the TCA cycle, de novo fatty-acid biosynthesis, and promoted the emergence of
aberrant intermediate markers. This leads us to hypothesize that HIF2 activation from
chronic injury to the
distal lung epithelium prevents AT2 cell regeneration from airway progenitors through epigenetic and metabolic
modulation of key AT2-requisite biosynthetic functions. We will test this hypothesis by 1) determining how
HIF2-activity modulates cellular fate and epigenetic programs during alveolar repair, and 2) delineating the
metabolic processes underlying HIF2 suppression of AT2 cell differentiation in the distal lung. These studies
will provide essential mechanistic insights in both murine and IPF patient-derived human models into the role
of HIF2 in alveolar epithelial remodeling, how its modulation affects adaptive repair, and establishes
foundational pre-clinical data for targeting HIF2 as a novel therapeutic strategy for IPF. The highly experienced
mentorship team assembled, which includes both physician and basic scientists as well as external advisors,
collectively brings expertise in lung epithelial biology, genome regulation, and molecular metabolism which is
ideally suited to support my training and career growth as I develop my independent research program.

Public health relevance
NARRATIVE Most patients with Idiopathic Pulmonary Fibrosis (IPF) succumb to their disease or require lung transplant within 5 years of diagnosis, and new treatments that stabilize disease or enable functional lung repair would be transformative for IPF patients. We have identified abnormal activation of the hypoxia-inducible-factor (HIF) pathway as a hallmark of dysfunctional lung repair in IPF. Using a combination of animal models of lung injury and human lung organoids derived from patients with IPF, this project will determine the mechanisms through which activation of the HIF pathway prevents lung stem cells from effectively repairing the injured lung, and test HIF-inhibition as a novel therapy to promote functional lung repair.